Host-Pathogen Dynamics in Microglia during C. neoformans and HIV Co-infection

Cryptococcus neoformans (CN) is a significant human pathogen causing chronic meningoencephalitis (CME), a
major contributor to mortality in AIDS patients, accounting for approximately 19% of deaths. This research project
aims to explore the phenomenon of replicative aging in CN, particularly its impact during infection in AIDS
patients. Replicative lifespan analysis reveals an accumulation of older CN cells in AIDS patients' cerebrospinal
fluid (CSF), highlighting a potential selection mechanism in the host environment. These aged CN cells
demonstrate a resilient phenotype, exhibiting enhanced resistance to macrophage-mediated killing. Microglia,
the predominant tissue-residing macrophages in the brain, are key players in CN infection in the central nervous
system (CNS). Microglia can be co-infected with HIV-1. These cells also contribute to the pathogenesis of HIV-
1-associated neurocognitive disorders (HAND) and create a niche that facilitates CN's intracellular growth.
Extracellular growth of CN is associated with the upregulation of a copper transporter (CTR4), which is crucial
for CN's survival in the brain. The overarching hypothesis of this research is that aged CN cells accumulate in
the CSF of AIDS patients due to their altered host-pathogen interaction with microglial cells. Ultimately, this leads
to heterogeneity of the in vivo expanding CN population, characterized by a generational distribution shift. Our
preliminary data suggest that old CNs’ resistance to phagocytic attack may be due to various physiological
changes during replicative aging, including cell wall remodeling, altered mitochondrial function, and the
expression of an efflux pump, which modulates the phagolysosomal pH. The proposed study is structured around
three specific aims: Aim 1: To investigate the host-pathogen dynamics in microglia co-infected with CN and HIV,
focusing on the survival strategies employed by aged CN cells. Aim 2: To determine if selective microglia
depletion changes the generational distribution of CN populations in both immunocompetent and CD4+ depleted
mice. Aim 3: To explore if serial isolates with altered RLS emerge in AIDS patients with CME. This research will
provide crucial insights into the survival mechanisms of CN in the brain of AIDS patients, with potential
implications for developing targeted therapies against CN infections in immunocompromised populations.

Public health relevance
We discovered that old fungal cells accumulate in the brain of AIDS patients. Old Cryptococcus cells are more resistant to killing microglia which is a macrophage like cell in the brain of infected AIDS patients. We propose to study this process in more detail because we believe it contributes to treatment failure.